INBRE Administrative Core

ADMINISTRATIVE CORE SUMMARY
The Hawaii State Research & Education Partnership (HiSREP) is an INBRE network consisting of our lead
university (University of Hawaii at Manoa; UH Manoa), 4 primarily undergraduate universities (PUIs), 1 UH
college and 4 UH community colleges (CCs), encompassing the institutions of higher learning in Hawaii
consenting to support from the INBRE program. The variety and capacity of the partner institutions located
throughout the islands of Hawaii require a strong Administrative Core to coordinate these activities and
synergize the efforts of those involved, including the campus coordinators, core directors, faculty, mentors, and
students. The major activities coordinated through the Administrative Core involve the development of
research faculty and implementation of high caliber research, facilitation of student education and skills
training, organizing workshop and enrichment activities for faculty/staff and students, and conducting
program evaluation. In addition, the Administrative Core will work closely with the Bioinformatics Core for
optimizing their efforts and expansion throughout the HiSREP. The Administrative Core will be led by
Principal Investigator (PI), Robert Nichols, Ph.D., along with the Program Coordinator (PC), Peter
Hoffmann, Ph.D. The PI will provide overall direction and general administrative support for the entire
HiSREP program. The PC will assist the PI with all activities and will assume primary responsibility for
communicating and coordinating activities among partner institutions. The Administrative Core will foster
collaborative interactions among partners and serve as a cohesive link between cores and activities. The PI
and PC, along with a strong administrative support staff, will receive guidance and evaluation by an Internal
Executive Committee (IEC), a Steering Committee, an External Advisory Committee (EAC), and an
Evaluation team. The PI and PC will also serve to liaise with INBREs from other states to discuss
approaches and strategies so that the Hawaii INBRE can improve its programs based on the experiences
of these other networks. Through effective planning and implementation, the Administrative Core will
greatly expand research capacity at our HiSREP partner institutions, increase the number and quality of
biomedical scientists, provide research education opportunities for students at all stages to inspire them to
pursue research in the health sciences, and provide a state-of-the-art bioinformatics facility to support our
Hawaii community of scientists.